Siderophore based molecular imaging of pulmonary infections

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is a progressive, debilitating respiratory condition with a clinical
course that is punctuated by acute exacerbations (AECOPD) ranging from self-limited episodes to florid
respiratory failure. AECOPD are most often precipitated by viral and/or bacterial infections. The bacterial
organisms that commonly play pathogenic role in AECOPD are Pseudomonas, Klebsiella, Acinetobacter, and
Enterobacter, and multidrug resistant Pseudomonas and Klebsiella pneumoniae are a common cause of
secondary pneumonias in hospitalized patients with COPD. The change in color of sputum indicative of
purulence that is often used as a surrogate marker for the presence of bacterial infection is a late, inconsistent,
nonspecific and insensitive biomarker; it cannot distinguish between viral and bacterial infection, and many
patients with AECOPD do not produce sputum at all. The availability of a targeted, pathogen-specific and
sensitive imaging modality that could detect bacteria in the lower airways and differentiation bacterial from viral
infection non-invasively would advance our understanding of AECOPD and facilitate development of preemptive
treatment paradigms. In this proposal, we intend on using these unique bacterial membrane transporters on
bacteria, and their distinct metallophores as PET reporter probes to localize and identify pathogenic live bacteria
in AECOPD. We will also evaluate the specificity and sensitivity of the robes in identifying the bacteria in co-
infection models with influenza virus (H3N2). We will further evaluate the responsiveness of the PET imaging
probe and modality to different antibiotics, against several clinical isolates of K. pneumoniae and P. aeruginosa.
If successful, the probes would be able to assist with identifying subclinical bacterial colonization of in patients
with AECOPD, to determine if the bacteria that are ultimately responsible for the infection are the same strains
that was found to be colonizing. This project will lay the foundation for a new technology platform that will open
avenues to explore the possibility of using the diverse array of metallophores as contrast agents for imaging the
entire repertoire of pathogenic infections.

Public health relevance
PROJECT NARRATIVE Pathogen-specific PET imaging probes will identify and quantify extent of infection of K. pneumoniae and P. aeruginosa in mouse coinfection models, differentiate viral from bacterial AECOPD, and serve as an effective quantitative imaging tool to track responsiveness to antibiotic treatment.